Improving the Human Reference Genome Resource

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.

Public health relevance
PUBLIC HEALTH RELEVANCE The reference human genome sequence is a powerful tool for research. However, portions of the sequence remain incorrect or missing. Also, ethnically diverse genome sequence data from several individuals will be added so that the reference genome sequence will be more useful for a broader number of experimental and clinical applications. In addition to remedying these problems, we will also provide community training.